NRI-Small: Chemo-Fludic Sleeve Muscle-Actuated Robotic Below-Knee Prostheses

DESCRIPTION (provided by applicant): The proposed project aims to develop a compact and light-weight robotic prosthesis, with the objective of significantly enhancing the health and life quality of the 400,000 transtibial (i.e., below-knee, BK) amputees in the United States. In human locomotion, the ankle plays an important energetic role, and supplies substantially more positive power than the knee and hip. However, in the majority of existing BK prostheses, the prosthetic ankle joints are energetic passive, only storing and dissipating energy in use. The inability to generate power significantly impairs the prosthesis' capability of restoring the locomotive functions for the amputee user. Clinical studies indicate:that amputees wearing passive BK prostheses exhibit asymmetric gait kinematics and expend significantly more energy in comparison with healthy subjects. To address this issue, the investigators will explore an innovative chemo-fluidic sleeve muscle actuation system to power the BK prostheses. Two key elements form the basis of this new system: (1) Sleeve muscle actuator, an innovative muscle actuator with very high power density (at least ten times higher than DC motor); (2) Highenergy- density pneumatic supply, which is able to store a large amount of energy within a highly compact package. With this high-performance actuation system, the prosthesis is anticipated to meet the demanding power requirements imposed by the human locomotion, while minimizing the prosthesis weight and height to enlarge the amputee population that can benefit from the new powered BK prosthesis. The breakthrough in actuation technology will be complemented with a novel intent recognition and motion control algorithm, which is anticipated to provide the user's desired motion in a highly interactive manner. This control system identifies the desired locomotive pattern based on the user's inferred motion intent, and generates the desired joint torque command though ah impedance-based motion controller that enables physical interaction between the user and the prosthesis. The robotic prosthesis and the corresponding control system will be further tested to characterize its biomechanical benefits relative to state-of-the-art passive BK prostheses.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project aims to develop a compact and light-weight robotic prosthesis, which will benefit the population of 400,000 transtibial (i.e., below-knee, BK) amputees in the US. Utilizing an innovative chemo-fluidic sleeve muscle actuation approach, this prosthesis will enable active power output to support the user's locomotion, and thus provide significant health benefit to the BK amputee relative to existing passive prostheses. __SpecificAimsTextDelimiter__ The research in this proposal is motivated by the desire to enhance the life quality of persons suffering from limb losses (especially lower limb losses), a large and rapidly growing population in the United States. Every year, more than 185,000 persons undergo a limb amputation, and the number of persons living with limb loss is expected to more than double from 1.6 million in 2005 to 3.6 million in 2050 [1 ]. According to the National Health Interview Survey, one out of 200 people in the U.S. has had an amputation [2]. By the site of amputation, below-knee (BK, also known as transtibial) amputees account for approximately 24% of the amputee population [3]. As such, restoring the lost limb and joint functions for these amputees makes a significant research topic. Biomechanical studies on human locomotion highlight the important energetic role of the ankle joint. In level walking, the ankle produces substantially more work than the knee and hip [4,5]. Unlike the knee, the energetic behavior in level walking is clearly and significantly positive (i.e, integration over a cycle of power data is clearly and significantly positive), as indicated in Fig. 1 [6]. Based on the data, the average power delivered is approximately 0.37W/kg (normalized by body weight), which will further increase with higher walking speed. It has also been shown that the ankle joint muscles generate an average of 540% more work than they store in a gait cycle [4]. In addition to the level walking, stair ascending also requires similar level of power output according to Riener et al. [7]. Despite the biological ankle's positive energetic behavior, existing BK prostheses (also known as ankle-foot prosthesis or prosthetic feet) have been limited to energetically passive devices, which only dissipates energy, or store and reuse energy within a gait cycle. The inability to generate power significantly impairs the prosthesis' capability of restoring the locomotive functions for the amputee user. To compensate for the lack of power generation on the prosthetic ankle, the amputee user has to expend more power on the unaffected biological joints, resulting in an asymmetric gait and greater energy consumption. For example, clinical studies showed that amputees with passive BK prostheses consumes 10-30% more energy for walking at the same speed than healthy subjects [8-10], and this discrepancy becomes more significant at higher walking speed [IV Inspired by this reality, the research in this proposal aims to establish a general actuation and control framework to enable the development of energetically-active (i.e., powered) BK prostheses, with the objective of significantly enhancing the mobility and life quality of the transtibial amputees. Note that, as a typical mobile robotic device, a powered BK prosthesis faces the challenge of generating sufficient power and torque output with a compact, energetically autonomous package (i.e., the prosthesis needs to carry all the energy supply onboard). To address this challenging issue, the research team will explore an innovative chemo-fluidic sleeve muscle actuation approach, which provides a siqnificantlv higher actuation performance than traditional electrical actuation svstems (i.e., batterv + DC motor combination). With this new approach, the resulting powered BK prosthesis is anticipated to meet the demanding power and torque requirements imposed by the human locomotion, while minimizing the prosthesis weight and height to enlarge the amputee population that can benefit from the new powered BK prosthesis. The breakthrough in the actuation technology will be complemented with a novel intent recognition and motion control algorithm, which is anticipated to achieve the user's desired motion in a highly interactive manner. Overall, the proposed research is anticipated to generate significant scientific findings in the robotic prosthetics area, benefiting the 400,000 transtibial amputees living in this country.